CORE--TRANSGENIC MOUSE FACILITY

AIMS: 1. To generate transgenic mice for the PPG investigators (by microinjection of DNA constructs into one-cell stage mouse embryos). 2. To establish cre and tet/R transgenic families that can be used to manipulate gene expression during cardiac development.